INCIDENCE OF ASPIRATION OF GASTRIC CONTENTS IN INTUBATED AND VENTILATED CHILDREN

The objective of this investigation is to determine the incidence of GER and reflux of gastric acid into the posterior pharynx in mechanically ventillated infants and children as a first step in determining whether aspiration of refluxed gastric acid is a factor in development of chronic lung disease.